Shedding light on the role of RNA binding protein-mediated RNA regulation in synaptic plasticity

Project Summary
Neurons have highly specialized structures and functions; their genetic information is often located a great
distance from the sites where information gets transmitted, and they must dynamically alter the synaptic
proteome in response to neural activity. These challenges indicate that neurons have evolved unique regulatory
mechanisms to meet functional demands. The uniformity of DNA across different cell types suggests that how
genetic information is unfolded and processed underlies cellular diversity. In this view, careful examination of the
regulation of RNA metabolism, how pre-mRNA gene copies are alternatively spliced and polyadenylated, edited,
localized, and translationally regulated, will offer a new avenue towards understanding complex processes, such
as synaptic plasticity underlying learning and memory. This notion has driven molecular neuroscientists to search
for factors that localize and regulate synaptic RNAs. We are only beginning to compile a list of these key
regulators, such as RNA binding proteins (RBPs), particularly in the synapses of hippocampal neurons that are
involved in memory, and to date very little is known about how these factors regulate RNA. Our laboratory has
recently generated a new platform for cell-specific Crosslinked Immunoprecipitation (CLIP) of RBPs in the living
brain of mice (cTag-CLIP), which has furthered our understanding of the cell-specific regulatory functions of
RBPs; however, this technology is limited to looking at steady state RNA regulation. Here we described a novel
approach to uncover the role of neuronal RBP-mediated RNA regulation in the context of synaptic plasticity. This
methodology, termed opto-CLIP, will combine the cell type-specific resolution afforded by cTag-CLIP with the
unprecedented precision of optogenetics to achieve non-invasive optical control of specific neurons. Once
established, we will increase the cellular resolution by performing opto-CLIP in distinct subcellular compartments
to assess local RNA regulation associated with neuronal function. This study will further our understanding of
RBP-mediated RNA regulation, enhance our knowledge of the role of RNA metabolism in synaptic plasticity, and
provide new insight into the pathological mechanisms underlying neurological disorders. In conclusion, I am
confident that my experience studying RNA biology, the Darnell lab's foundation in neuroscience and CLIP, and
the rich research environment at Rockefeller University will help me succeed in using optogenetics to study the
role of RBP-mediated RNA regulation in synaptic plasticity.

Public health relevance
Project Narrative Our ability to understand and treat neurological disorders is limited by the gaps in our knowledge of the regulatory mechanisms that enable synaptic plasticity. Neuronal RNA binding proteins (RBPs) are essential regulators of RNA metabolism and have been implicated in diseased states. This study will seek to characterize RBP-RNA interactions in functioning neurons to uncover novel regulatory mechanisms that promote synaptic plasticity underlying learning and memory.